Biostatistics

The mission of the Biostatistics Shared Resource (BSR) is to serve as a focal point for cancer center members to obtain assistance in the design, management, and analysis of their studies. The services provided by the BSR include: 1. Biostatistical collaboration and consultation in the design of clinical trials, observational studies, and laboratory studies. An appropriate statistical design is necessary if the research is to be successful in fulfilling its scientific objectives. 2. Statistical expertise in data analysis. The specific methods employed depend on the randomization or sampling design of the particular project and on the scale (binary, ordered categorical, or continuous) of the outcome variable being investigated. Statistical data analyses are performed using both packaged and special purpose computer programs. 3. Scientific review, quality control, and data and safety monitoring for clinical trials. 4. Education; through formal and informal seminars, courses and lectures; and the development of statistical methodology necessary for meeting the scientific objectives of cancer center studies. In general, the BSR attempts to emphasize the importance of ongoing and continuing collaboration with biostatisticians during the entire research effort, rather than one-time consultation without appropriate context.

Public health relevance
RELEVANCE (See Instaictions): Statistical support is essential for rigorous science. The Biostatistics Shared Resource provides high-quality statistical support for clinical and for laboratory investigators.